Improving Sleep and Functioning in Veterans with Posttraumatic Stress Disorder

Sleep disturbance is the most common symptom among Veterans with posttraumatic stress disorder
(PTSD), with prevalence rates of over 90% for insomnia and around 70% for obstructive sleep apnea (OSA).
Beyond symptom-driven distress, PTSD, OSA, and insomnia are problematic because of their effects on
physical health, functional outcomes, and quality of life. While there are effective treatments available for OSA
and insomnia, current treatments for these disorders have not been adapted to the needs of the large number
of Veterans experiencing PTSD. This adaptation is necessary to target the problems that are particularly
detrimental to this group of Veterans. For example, patients with PTSD have lower positive airway pressure
therapy (PAP) adherence than those without PTSD, which is significant because increased adherence to PAP
is associated not only with reduced nightmares but also with improved PTSD symptoms overall. In addition,
though behavioral treatments for insomnia have been studied in those with PTSD with promising results, little
is known about how to address comorbid OSA and insomnia because patients with OSA are typically excluded
from insomnia trials in spite of high levels of comorbidity. Moreover, insomnia itself is associated with
decreased PAP adherence. Currently, there is no integrated approach to treating Veterans with these
comorbidities concurrently, and existing treatment is often not coordinated between different treatment clinics
and consequently may be more prolonged than needed. The proposed project allows for the evaluation of a
treatment that addresses OSA and insomnia in tandem and within the context of PTSD, which can serve to
consolidate treatment for Veterans with these issues.
The proposed CDA-2 consists of a pilot randomized controlled trial evaluating the efficacy, feasibility,
and acceptability of Apnea and Insomnia Relief (AIR), a behavioral intervention that combines elements of
psychoeducation, motivational interviewing, cognitive behavioral therapy for insomnia, and PAP
desensitization. The trial will compare AIR (n = 40) with sleep education (control condition; n = 40) among
Veterans with OSA, insomnia, and PTSD. Treatment will be administered partially in person (sessions 1-2) and
partially via telehealth (sessions 3-6) to enhance Veteran engagement and broaden access to care. Functional
outcomes will be quality of life (primary outcome) and sleep-related functioning at post-treatment and three-
month follow-up (Aim 1). We will also measure change in insomnia and PTSD symptoms as well as PAP
adherence. Insomnia symptoms will be assessed using subjective and objective sleep measurement. Aim 2
will consist of a multifaceted assessment of the acceptability and feasibility of AIR. Veterans will complete self-
report questionnaires and a follow-up interview to assess satisfaction with treatment, both in terms of content
and method of delivery (i.e., in-person and telehealth). We will also measure treatment dropout and attendance
at the first PAP follow-up appointment to evaluate engagement in care. Finally, we will conduct an exploratory
analysis of moderators of treatment outcome (Aim 3), such as baseline sleep apnea severity or concurrent
medication use, to facilitate adjustments to the protocol or identify subpopulations for whom an alternative
treatment may be recommended.
The proposed project could be highly impactful for the increasing number of Veterans with PTSD and
sleep disturbance, as well as their providers who lack clear guidelines for how to provide behavioral treatment
for sleep disorders in patients with PTSD. Moreover, by treating these disorders concurrently, there may be an
improvement in Veterans’ functioning and a reduction in service utilization. This intervention is consistent with
the VHA mission of providing exceptional healthcare. Additionally, the proposed intervention is in alignment
with the VHA vision of providing patient centered and evidence based care delivered by engaged and
collaborative teams in an integrated environment.

Public health relevance
Sleep difficulty is a hallmark symptom of Posttraumatic Stress Disorder (PTSD), one of the most common mental health diagnoses among Veterans. Specifically, sleep apnea and insomnia are highly prevalent among Veterans with PTSD and are associated with decreased functioning, reduced quality of life, and increased negative health outcomes. Though effective treatments are available for sleep apnea and insomnia separately, care for these sleep disorders is often provided in a piecemeal, uncoordinated approach without adaptation to the specific needs of those with PTSD. There is a significant gap in providers’ knowledge of how to treat these disorders in tandem, resulting in prolonged functional impairment for Veterans and increased burden on the healthcare system. The proposed research promotes an innovative, collaborative approach to treating sleep apnea and insomnia in Veterans with PTSD using proven behavioral techniques known to improve sleep. The combined in-person/telehealth approach will improve access to care and quality of care offered to Veterans.